2025 Epithelial Differentiation and Keratinization Gordon Research Conference and Gordon Research Seminar

Project Summary
The 2025 Gordon Research Conference on Epithelial Differentiation and Keratinization (GRC-EDK) is the
leading international meeting in the field of epithelial biology. Since its inception in 1979, the biennial GRC-EDK
has contributed to scientific advances and shaped therapeutic approaches for treating skin conditions. For over
four decades, the GRC-EDK has had a high level of attendance, the consistent participation of world-renowned
experts in the field, and highly favorable reviews from conference attendees. The 2025 GRC-EDK conference
is entitled "Epithelial Development, Aging, Disease, and Regeneration Across Cells and Systems" and
will take place in Ventura Beach, California, from June 1-6, 2025. The 2025 GRC-EDK will celebrate its
46th year, continuing its tradition of addressing cutting-edge basic questions in epithelial biology and ways
of translating these discoveries into disease treatment. It will showcase recent conceptual and technological
advances comprising stem cell biology, regenerative medicine, cancer, immunity, aging, epigenetics, skin
diseases, novel single-cell and spatial transcriptomics technologies, and global genomics. GRC-EDK also
acts as a platform to support the careers of a full range of investigators, including women and men, young
investigators, and investigators from different cultural and ethnic backgrounds. More than 15% of the invited
speakers are from fields beyond the immediate scope of the conference, 85% did not present at the previous
meeting, and over 30% of speakers will be selected from abstract submissions to ensure plentiful opportunities
for junior faculty and trainees. The relatively secluded location for the 2025 GRC-EDK and the allocated
informal afternoon periods are chosen to maximize the potential for in-depth scientific discussions,
mentoring, and the initiation of collaborations among conference participants. The power hour is an
important part of the GRC-EDK meeting and will encourage discussions on overcoming discrimination and
facilitating diversity and inclusion in the scientific community. The commitment to nurturing the next generation
of scientists will continue with the 6th Gordon Research Seminar on Epithelial Differentiation and
Keratinization (GRS-EDK), scheduled at the same location and just before the main conference from
May 31-June 1, 2025. This seminar is organized by and for trainees and offers a supportive environment for
presenting research, networking, and fostering collaborations. A career mentoring panel at the GRS-EDK will
address key topics such as career development, choices between academia and industry, and the critical
importance of diversity in science. Taken together, the 2025 GRC/GRS-EDK exemplifies the NIAMS institute's
strategy with the following main objectives: (i) to advance pioneering research in skin biology, (ii) to facilitate
the transition of scientific discoveries to clinical practice, and (iii) to support the professional
development of early-career scientists and trainees to sustain innovation in the field.

Public health relevance
Project Narrative Since 1979, the biennial Gordon Research Conference on Epithelial Differentiation and Keratinization (GRC- EDK) and its associated, trainee-run Gordon Research Seminar on Epithelial Differentiation and Keratinization (GRS-EDK) have served as a pivotal platform to showcase the latest conceptual and technological advances aimed at addressing fundamental questions in epithelial biology and to advance scientific discoveries into treatments for human disease. The 2025 GRC/GRS-EDK will focus on areas such as stem cells and homeostasis, epithelial tissue organization and niche signaling, immunology, epigenomics, cutting-edge technologies, and innovative therapeutic approaches. The 2025 GRC/GRS-EDK meetings aim to present breakthrough discoveries in these fields, encourage the free exchange of ideas, facilitate interactions and new collaborations, and promote discussions on enhancing diversity and inclusion in the scientific community.